CONTRACEPTIVE CLINICAL TRIAL NETWORK (FEMALE)

The N"ICHD's Contraceptive Clinical Trials Network conducts Phase I, II and III clinical trials of a wide variety of new female and male contraceptive methods. The objective of this contract is for CCTN contractors to conduct female contraceptive trials, conduct treatment trials of gynecologic conditions, and to develop research protocols on a task Order basis under an Indefinite Delivery/Indefinite Quantity (IDIQ) contract.